Project 3: Racial and ethnic differences in the intra-tumoral microbiome: Impact on colorectal cancer mortality and clinicopathologic correlates

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) incidence and mortality vary greatly by race and ethnicity in the United States (US).
Alaska Native people have among the highest reported rates of CRC in the world; African American people also
shoulder an elevated burden of CRC compared to other groups in the US. This disproportionate burden of CRC
is marked by differences in the distribution of clinicopathologic factors (e.g., tumor site, age at CRC onset,
consensus molecular subtypes) by race and ethnicity, which also has implications for outcomes. In exploring
factors that may contribute to these observed disparities, minimal consideration has been paid to the potential
contribution of the microbiome. The presence of a gut microbial community is common across all human
populations, but the composition of that community varies greatly – by sex, diet, and race and ethnicity. The
composition of the gut microbiome has plausible implications for a variety of pertinent health outcomes, including
CRC. Increasing evidence indicates that specific gut bacteria, or imbalances in bacterial populations, could play
a role in the natural history of CRC. Prior studies have implicated a small number of candidate bacteria (e.g.,
Fusobacterium nucleatum; Fn) as contributors to CRC etiology and survival; however, our early studies suggest
these candidates are unlikely to be significant contributors to CRC disparities. Instead, we are identifying novel
candidate bacteria that are disproportionately prevalent in tumors among Alaska Native and African American
patients with CRC. The objective of this project is to test our overarching hypothesis that specific racial and
ethnic differences in the tumor microbiome contribute to disparities in CRC attributes and outcomes. In pursuit
of this objective, we will leverage and build upon existing biospecimen and data resources, infrastructure, and
preliminary findings accumulated through the Translational Research Program in Colorectal Cancer Disparities
(TRPCD). In Aim 1, using quantitative digital droplet PCR (ddPCR) assays, we will: (1a) test for differences in
the prevalence and abundance of novel candidate bacteria in colorectal tumors across four racial and ethnic
groups (Alaska Native, African American, Hispanic, and non-Hispanic White patients with CRC), and (1b) test
for associations with risk of lethal CRC overall and within racial and ethnic groups. For Aim 2, we will expand
our evaluation of (2a) these novel candidates and (2b) microbial 16S rRNA gene sequencing (16S rRNAseq)
data to examine relationships with clinicopathologic factors, with a focus on attributes that differ in their
distribution across racial and ethnic groups and have implications for outcomes. In Aim 3, we will use artificial
intelligence, such as machine learning strategies, to identify tumor-associated microbial signatures in CRC
associated with CRC-specific mortality and will assess differences in the distribution of those signatures by race
and ethnicity. Integration of the results from our aims can be used to inform more targeted cancer treatment
strategies, particularly in understudied populations experiencing the greatest burden of CRC.

Public health relevance
PROJECT NARRATIVE The burden of colorectal cancer incidence and mortality varies greatly across population groups. In this project, we will examine the role of bacteria in colorectal cancer across population groups to identify differences in the presence and distribution of different bacteria – individually and in combination. The findings from this work will help us better tailor cancer treatments and early detection in the future to address colorectal cancer differences across population groups.